69th Annual Coccidioidomycosis Study Group Scientific Conference

PROJECT SUMMARY
Funds are requested to provide partial support for the 69th Annual Conference of Coccidioidomycosis Study
Group (CSG) to be held on April 5-6, 2025, hosted by the Arizona State University Health Futures Center in
Phoenix, Arizona. CSG prides itself on bringing the largest group of coccidioidomycosis researchers together
to share the latest clinical and basic laboratory findings, provide opportunities for collaboration, and especially
to promote the development of junior trainees. Researchers, physicians, veterinarians, other healthcare
providers, epidemiologists, and various trainees (students/residents/fellows/postdocs) from over 30
laboratories have attended annually. The CSG typically rotates between Arizona and California, but the 68th
CSG was in San Antonio which is at the edge of the endemic region. A growing number of medical mycologists
have attended this meeting, leading to its longevity and significance over the past 68 years.
Although the meeting format has evolved over the years, the current format focuses on oral and
poster presentations by trainees regarding their most exciting and impactful research data. The small
group setting provides a welcoming environment that successfully promotes discussion and constructive
feedback for trainees. The program includes seven scientific sessions with 38-40 slots for trainees’ oral
presentations, a poster session, a keynote speaker, a business meeting hour, and a sponsor-funded banquet.
The small group setting in the planned program and attendance by PIs and trainees is excellent for
networking and promoting trainee development Dr. Thuy Le, a renowned medical mycologist from Duke
University in the area of talaromycosis has accepted our invitation to be the 2025 keynote speaker. We request
10 travel awards ($750 each) for trainees to present in-person and to encourage more early career scientists to
attend the meeting. Travel award recipients will be selected on the basis of their application for (i) need of
travel support and (ii) quality and merit of their research. Aligning with DEI requirements, we will also assign a
higher priority for women and minority trainees as well as anyone challenged with a physical disability.

Public health relevance
PROJECT NARRATIVE The Goal of this R13 Scientific Conference application is to partially fund the 69th annual Coccidioidomycosis Study Group at the Arizona State University Health Futures Center in Phoenix, AZ. Phoenix is in Maricopa county, AZ which has more yearly cases of coccidioidomycosis (Valley Fever) diagnosed than any other location in the world. This meeting is an opportunity for clinical and basic science researchers to exchange information and for young investigators and trainees to present their findings to the Valley Fever community in a diverse, equitable and inclusive environment.